Alternative splicing mechanism in stress.

PROJECT SUMMARY/ABSTRACT
This proposal represents a highly innovative line of research focusing on the role of pre-mRNA splicing in
the pathophysiology of chronic stress. Chronic stress is a major risk factor for many neuropsychiatric
disorders, including major depressive disorder, anxiety disorder, post-traumatic stress disorder (PTSD),
schizophrenia, and addiction. Neurotransmission and synaptic plasticity are known to be dysregulated by
chronic stress, leading to long-term neuronal dysfunction and altered emotional and cognitive behaviors.
We have novel data showing the dysregulation of splicing factors in the brains of chronically stressed
animals. Furthermore, our findings indicate a role for upstream regulatory splicing factors in mediating
synaptic function. Dysregulation of pre-mRNA splicing events can lead to neuronal dysfunction due to
aberrant protein expression levels and expression of protein isoforms with altered functions. Therefore,
we propose to investigate a regulatory pre-mRNA splicing mechanism for the neuronal dysfunction arising
from chronic stress. We will do so using animal and cellular models to determine the precise roles of pre-
mRNA splicing elements in neuronal function and behavior, and to elucidate how they are dysregulated in
chronic stress. We expect results from the proposed studies to provide novel insights into the cellular and
molecular mechanisms underlying stress-induced neuropathology and behavior, and to identify potential
candidates for future translational therapeutic strategies for stress-related neuropsychiatric disorders and
addiction. The studies proposed in this application will provide a strong foundation for furthering our
understanding of how pre-RNA splicing events maintain the functional integrity of the CNS as it responds
to chronic stress and will inform future stress-related translational studies in major depressive disorder,
anxiety disorder, PTSD, schizophrenia, and addiction.

Public health relevance
PROJECT NARRATIVE This grant proposes to investigate a potential mechanism underlying neuronal dysfunction in chronic stress mediated by upstream regulatory pre-mRNA splicing elements. Splicing events have been reported for genes involved in many aspects of the central nervous system (CNS), and pre-mRNA splicing is a major neuronal mechanism for adaptation to stress. Elucidating the specific roles of spliceosomal components in the CNS will facilitate understanding of how dysfunction of pre-mRNA splicing affects the functional integrity of the brain, and provide novel insights into the etiology of stress-related neuropsychiatric disorders.